Validating RDoC for Children and Adolescents: A Twin Study with Neuroimaging

DESCRIPTION (provided by applicant): This application proposes a two-part approach to understanding developmental aspects of the RDoC positive and negative valence systems. The project focuses on objective behavioral assessment and multimodal neuroimaging. Study 1 takes advantage of 1404 children (702 twin pairs) previously objectively assessed as 7 year-olds on positive and negative affect with a battery of videotaped behavioral measures that map onto RDoC dimensions. These children had also been assessed as toddlers and were later assessed at mean age 14 years, which allows for longitudinal tests of construct validity of the RDoC systems as applied to children. Study 1 includes completion of the age 14 data collection. Study 2 proposes to follow-up, at mean age 18 years, 640 of these participants (320 same-sex twin pairs) with comprehensive neuroimaging and concurrent psychophysiological and neuropsychological measures that assess selected RDoC constructs from the positive and negative valence systems. We will determine whether standing on the childhood RDoC measures (from Study 1) predicts adolescent neuroimaging measures of reactivity and recovery of positive and negative affect (from Study 2). We will test predictions concerning correlates of standing on RDoC constructs using structural and functional connectivity and dynamic features (reactivity and recovery) of responses to affective stimuli in an automatic emotion regulation task. We use the twin design to discern whether individual differences are genetically conditioned and whether the covariance across time (stability of RDoC) and the covariance between behavioral and neural measures (neural underpinnings of RDoC) have genetic bases. We investigate environmental bases of RDoC constructs by predicting monozygotic intrapair differences in neuroimaging parameters from earlier intrapair behavioral RDoC differences and from earlier measures of adversity and stress.

Public health relevance
PUBLIC HEALTH RELEVANCE: The project's main public health relevance lies in its extension of NIMH's Research Domain Criteria initiative to children and adolescents. Deriving measures of the positive and negative valence constructs from overt behavior of children facilitates integration of pediatric and adult perspectives on RDoC. Investigating the dynamic nature of reactivity and recovery in both behavioral and neural responses deepens understanding of RDoC constructs. Multimodal neuroimaging at follow-up helps to establish the neural underpinnings of positive and negative valence systems. The longitudinal and quantitative genetic aspects of the project help to establish developmental antecedents of positive and negative valence systems.